Magnetic nanocomplexes-induced immunomodulation for fracture healing

Non-healing fractures are a cause of severe disability and have devastating effects on the quality of life.
Currently, there are no reliable first-line therapies that stimulate healthy bone formation and prevent nonunion.
There is a growing body of evidence supporting the indispensable role of macrophages in fracture healing.
Also, macrophage dysfunction is a critical component in the pathogenesis of non-healing or poorly healing
fractures. Immunomodulatory strategies that apply biochemical factors are gaining traction to regulate
macrophage phenotypes. However, they have limited success due to complications with specificity, efficacy,
and systemic toxicity.
Here we propose to develop a magnetic iron-oxide nanocomplexes (MNC)-based therapy for promoting
fracture healing. The cytoskeletal dynamics of macrophages are intricately linked to their inflammatory
response. Our studies confirmed that the cytoskeletal dynamics of macrophages are determined by their
phenotype. Studies also show that mere manipulation of cytoskeletal dynamics using physical cues, without
any exogenous factors, is shown to transform macrophage phenotype. This phenotype modulation is due to
the nuclear translocation of the transcription factor MRTF-A, and changes in chromatin compaction caused by
cytoplasmic-to-nuclear redistribution of histone deacetylase-3 (HDAC3). We hypothesize that intracellular
magnetic force can elicit transcriptional control of macrophage phenotype and promote fracture healing via
MRTF-A release and HDAC3 redistribution.
In SA1, we will engineer magnetic nanocomplexes for targeted internalization and mechanistically
elucidate intracellular force-induced modulation of the cytoskeleton and corresponding change in macrophage
phenotype. In SA2, we will validate macrophage targeting of MNC and elucidate their therapeutic potential in a
murine critical-sized femoral defect. The proposed research will be a paradigm shift in wound healing and will
also provide crucial insights into the mechanobiology of macrophages that are valuable for diagnostic and
therapeutic interventions.

Public health relevance
Regenerative medicine holds much promise for treating various ailments, including organ failures, age- related pathologies, and trauma-related injuries. While most of the current research focus is on developing biomaterials and methods for controlling the fate of multipotent stem cells, little is known about the host response primarily due to macrophages and the interconnectivity between inflammation and functional integration. This proposed research will investigate the mechanobiology of macrophages and develop methodologies that harness the body’s natural processes for augmenting bone regenerative therapies.